Initiative for Maximizing Student Development at the University of California, Davis.

PROJECT SUMMARY/ABSTRACT
The overarching goal of our IMSD at UC Davis Training Program is to increase the diversity of the biomedical
research workforce by increasing the number of diverse students who complete PhDs in biomedical-related
science fields. For this renewal, we propose to implement an enhanced comprehensive intervention program
that has rigorous research, educational, and community-building activities specifically for first and
second-year diverse graduate students. While UC Davis ranks second in the United States for producing the
highest number of PhDs for Hispanic students in biological/biomedical sciences, insights gathered from our IMSD
trainees and alumni through surveys, as well as interviews, indicate areas for improvement. Over the past five
years, we have observed a notable rise in the acceptance rate of underrepresented (UR) graduate students from
the initial offer to their formal acceptance into the life science programs at UC Davis. As part of the IMSD
program, incoming trainees will engage in a pre-matriculation four-week boot camp and attend weekly seminars
specifically designed for acclimating to and succeeding in graduate school. We propose to select 8 graduate
students each year to participate in this two-year Program. These students will join laboratories of exceptional
faculty with strong research programs, exceptional mentoring skills, and a passion for training the next generation
of PhDs, as well as engage in thoughtfully developed IMSD program activities. The IMSD Training Program has
four major objectives. The first objective is to increase the number of diverse students awarded PhDs in life
science disciplines. As part of this objective, it is expected that our efforts will result in at least 80% of trainees
completing their PhD requirements. Our second major objective is the enhancement of the mentor-trainee
relationship. Our third objective is to develop the outreach/communication and career skills of the IMSD trainees.
The fourth objective is to utilize program evaluations to continuously improve the program and provide expedient
dissemination of the results. Unlike the current IMSD program, which provides training for students solely in their
first year, the renewed IMSD program is designed to extend training over two years. In the current one year of
training the focus is on well-being, oral and written communication, a sense of belonging, and rigor and
reproducibility. In the proposed second year of training, our focus will shift towards career readiness skills,
including enhanced oral and written communication, bioinformatics skills, qualifying exam preparation, critical
thinking, and creativity skills in the biomedical sciences. Furthermore, we aim to provide increased access for
students to explore a variety of career options during this extended training period and help students develop
other life-relevant skills, such as financial management. We anticipate that our enrichment activities will continue
to increase the diversity of the life science pipeline by facilitating the successful advancement of UC Davis PhD
students to the next step of their biomedical research career.

Public health relevance
PROJECT NARRATIVE The overarching goal of this IMSD Training Program is to increase the diversity of the biomedical research workforce by boosting the number of students from diverse backgrounds who successfully earn PhDs in biomedically related science fields. To achieve this, we aim to consistently refine and execute comprehensive intervention programs, encompassing research, education, mentoring, and community-building initiatives for graduate students. We anticipate that our carefully developed enrichment activities will enhance inclusivity and belonging for those underrepresented in the biomedical workforce and produce resilient and highly skilled scientists who are successful in their dissertation research and who will thrive in the next step of their biomedical research career.